Project 2: Sparing in Tumor Free Animals

PROJECT SUMMARY – PROJECT 2
We are proposing the creation of a research program entitled, “Increasing the therapeutic index of brain tumor
treatment through innovative FLASH radiotherapy (FLASH-RT), focused on translating a novel irradiation (IR)
modality rapidly into the clinic. The overall hypothesis to be tested is whether radiation delivered at ultra high
dose rates (compared to the much lower dose rates used in current clinical practice) can significantly
ameliorate normal tissue complications while maintaining acceptable if not improved tumor control. To test this
hypothesis, the program will deploy a comprehensive series of preclinical studies that will critically evaluate
tumor control, neurocognitive outcomes and resultant radiation injury to the brain following FLASH-RT and
conventional dose rate irradiation. Collectively, these studies will generate the requisite data sets required for
the rapid translation of the novel FLASH irradiation platform to the clinical scenario. Preclinical studies in mice
assessing orthotopic tumor control, cognition, neuronal and vascular structural plasticity, immune-modulation
and oxygen dependent mechanisms of radiation injury are coupled with a clinical trial in GBM dog patients to
inform the oncologists of the potential benefits of this potentially paradigm shifting technology. The objectives
of this program project will be facilitated by the activities conducted by the dosimetry/physics core (Core 2) and
the Neurobehavioral Core (Core 3).
The current project (Project 2) involves a comprehensive series of cognitive, structural and immunological
studies that will elucidate the long-term (up to 6 months) impact of clinically relevant brain tumor treatments on
cognition under carefully controlled conditions. Animals subjected to single fraction IR, multifraction IR, and
multifraction IR +/- TMZ treatment arms will be behaviorally tested then analyzed for some of the critical
neuronal and vascular changes essential for proper cognitive function. For this project, these proof-of-principal,
long-term neurocognitive studies must be made in tumor free animals in the absence of confounding disease,
and will provide the foundation for elucidating the basis normal tissue sparing afforded by FLASH in the
irradiated brain.

Public health relevance
PROJECT NARRATIVE – PROJECT 2 Radiotherapy remains a frontline treatment for primary and metastatic brain cancers, like Glioblastoma multiforme (GBM), but can result in debilitating cognitive side effects. The proposed program seeks to evaluate FLASH, a new radiation delivery platform that has shown strong promise for eradicating cancer cells with significantly less harm to surrounding healthy tissue than is possible with current radiotherapies. This project involves a series of long-term neurocognitive studies that will provide insight into the mechanisms of how normal tissue damage is spared by FLASH.